Administrative Core

Enteric Cooperative Centers on Human Immunology (Enteric CCHI)
University of Maryland, Baltimore
Enteric CCHI Administrative Core
ABSTRACT
The Administrative Core for the Enteric Cooperative Centers on Human Immunology (Enteric CCHI) will be based
at the Center for Vaccine Development and Global Health (CVD), University of Maryland, Baltimore (UMB). The
key role of the Enteric CCHI Administrative Core is to comprehensively coordinate, manage, organize, facilitate,
evaluate, and supervise investigators and institutions to ensure that highly productive research efforts are
supported within a strong collaborative environment. The full purview of Administrative Core activities includes
fiscal oversight, resource management and prioritization, communication, coordination, data management and
sharing, protection of intellectual property, regulatory compliance, and involvement of University of Maryland,
Baltimore institutional resources with the goal of efficiently supporting and facilitating research timelines and
milestones for the successful implementation of CCHI objectives.
The Enteric CCHI Administrative Core will be led by its Principal Investigator and Director, Marcelo B. Sztein,
M.D., who will oversee coordination efforts among the Research Projects and Cores and will work to foster a
strong collaborative environment. Additionally, the Enteric CCHI Oversight Committee will facilitate interactions
and support the Principal Investigator in monitoring scientific research.
A highly experienced administrative team at the CVD has successfully managed two previous award cycles of
U19 CCHI (Dr. Sztein, PI). In addition, the administrative team has served as the lead for many other multi-site,
multi-project grants and cooperative agreements. The breadth and depth of experience over such a diverse
group of grants and contracts is indicative of the proficiencies of this highly competent Administrative Core, which
is poised to manage the Enteric CCHI.